Hyperpolarized C-13 MRI Techniques to Monitor Radiation Therapy Response in Prostate Cancer Patients

Project Summary/Abstract
The goal of this research project is to investigate new 3D advanced hyperpolarized (HP) 13C-pyruvate MRI
techniques to quantitatively monitor metabolic changes in prostate cancer following stereotactic body radiation
therapy (SBRT) and to study HP 13C + multiparametric 1H MRI for detecting residual/progressive cancer following
RT, addressing current unmet clinical needs. This research trial is important because RT too often causes excess
morbidity without sufficient efficacy and current imaging approaches are inadequate in identifying clinically
significant cancer following RT. FDG-PET imaging is significantly limited in prostate cancer since in the localized
setting, significant excretion in the bladder precludes the ability to adequately detect signal within the prostate
and even in the metastatic setting there is significant heterogeneity of uptake with substantial proportion of non-
FDG avid, yet still metabolically active and growing tumors, for reasons related to intra-cellular uptake and
trapping of the FDG tracer. While we use PSMA-PET, to identify metastatic prostate cancer, it does not provide
the metabolic information on prostate cancer aggressiveness and response to therapy that HP 13C has
demonstrated in preclinical and initial human studies at our and other sites.
Recent patient studies of this emerging imaging approach at multiple sites world-wide have shown repeatable
findings of greatly up-regulated LDH catalyzed pyruvate-to-lactate conversions in cancer using this safe, rapid,
fast <5 min, non-radioactive molecular HP 13C MRI. It has demonstrated not only feasibility, but also valuable
biomedical information at costs similar or less than PSMA-PET and other PET exams. This project aims to study
two groups of patients with multiparametric (mp) 1H MRI with HP 13C-pyruvate MRI (HP 13C mpMRI); 1) Before,
3 months after, and 1 year following SBRT; and 2) patients exhibiting “biochemical failure” indicated by a rising
PSA after radiation therapy who are going on to image-guided biopsies prior to selection of further salvage
treatment. We strengthened this resubmission by addressing the prior critiques and including new preliminary
data applying new improved HP technology. Our multidisciplinary research team has extensive experience in
conducting early phase clinical trials and combines the expertise of prostate cancer imaging scientists with
physician/scientists and radiation oncologists to advance our preliminary studies to translate and investigate new
HP 13C-pyruvate mpMRI techniques for monitoring RT response in order to address important unmet clinical
needs in the treatment of prostate cancer patients.

Public health relevance
PROJECT NARRATIVE The goal of this project is to develop new techniques and apply an innovative MR molecular imaging approach to monitor HP pyruvate metabolism in prostate cancer patients pre- and post-radiation therapy for the first time. While this study focuses on prostate cancer radiation therapy, these methods are designed to be applicable to other prostate cancer HP MRI studies and in general to other cancer investigations.